Chromatin and Gene Analysis Core

PROJECT SUMMARY ? CHROMATIN AND GENE ANALYSIS CORE The Chromatin and Gene Analysis Core provides the technical and bioinformatics infrastructure to optimally mine the large amount of genome-wide gene expression and chromatin data that are generated from the Center's work. Center investigators lead the field in several aspects of genome-wide chromatin analyses, including pioneering these approaches in brain, which offers several technical challenges. We have optimized methods for several next generation sequencing approaches, including RNA-seq, ChIP-seq, ATAC-seq, in situ HiC, and whole genome bisulfite sequencing, among others, for mouse and human brain, the latter offering an additional set of unique technical challenges. These approaches are being used increasingly to study individual cell types within a given limbic brain region, in both mouse and human. The Core has established expertise in analyzing the highly complex datasets obtained, and will continue work on further improving the tools available. All of the genome-wide data generated by our Center are analyzed by this Core. In parallel, the Core runs routine genome-wide assays on defined animal models, with the Animal Models Core, and thereby provides a foundation for the more specific and sophisticated measures in the individual Projects. Indeed, each Project focuses on genes that are among the most robustly regulated across mouse depression models and human depression. As well, the Core pilots novel experimental technologies; an example is our ability to target single chromatin modifications to a single gene within a single brain region and cell type in vivo, thus providing an unparalleled level of proof to establish epigenetic mechanisms of depression. By consolidating the analytical work and routine genome-wide analyses within a centralized Core, we ensure rigorous control over the data and facilitate comparisons of experimental findings across the four individual Projects. This consolidation also makes financial sense, since we concentrate and maximize efficient use of our expertise. Finally, the Core is responsible, with the Administrative Core, in maintaining a platform for sharing our genome-wide datasets and analytical tools across the Center's laboratories as well as with the scientific community and lay public at large.